Research Project 1: Mechanisms of PFAS hepatotoxicity: A Multi-Omics Study Using Human Liver Spheroids

RESEARCH PROJECT 1 (RP1): PROJECT SUMMARY
Humans are ubiquitously exposed to per- and polyfluoroalkyl substances (PFAS), a group of man-made
chemicals that contaminate drinking water sources throughout the United States and are linked nonalcoholic
fatty liver disease (NAFLD), a serious liver condition that can lead to cirrhosis and liver cancer. However,
the critical gaps in the current knowledge limit the development of tools to identify individuals at high risk of
PFAS-induced NAFLD. Therefore, RP1 of ShARP will primarily address the Superfund Research
Program (SRP) Mandate 1 by identifying the biological mechanisms by which PFAS disrupt liver
metabolism. Our central hypothesis is that the metabolic changes caused by PFAS exposure in the liver favor
NAFLD development and progression, and those changes may not be reversible after prolonged PFAS
exposure. RP1 propose a multi-omic study to investigate PFAS impact on liver metabolism with an
experimental approach that will evaluate the effects of PFAS exposure on 3D liver spheroid models using a
combination of single-cell transcriptomics and epigenomics, proteomic and metabolomics assays, and spheroid
histology. RP1 will collaborate with RPs 2, 3, and 4, and Cores to address all SRP mandates and achieve
the ShARP Center's overall goals of developing a problem-based, solution-oriented center to address
the issue of PFAS water contamination in multiple Superfund Sites across the United States. RP1 will help
to address Mandate 2 in collaboration with RP2 (human cohort study) by reproducing in vitro the PFAS
concentrations and ratios found in the plasma of Southern California residents and generating
biomarker panels to identify individuals at high risk of PFAS-induced NAFLD. RP1 will help to address
Mandate 3 in cooperation with RP3 (environmental study) by evaluating the toxicity of legacy and emerging
PFAS found in high concentrations in Southern California drinking water sources. RP1 will help to address
Mandate 4 by designing experimental approaches with RP4 (remediation study) to determine the hazardous
effects of byproducts generated by PFAS defluorination. DMAC will help RP1 integrate the transcriptomic,
proteomic, metabolomic, and spheroid histological findings. CEC will help RP1 translate the scientific findings
into layman's terms to inform the community about PFAS health effects. RETCC will coordinate with RP1 the
trainees involved in the project implementation. RP1 will rely on the Administrative Core to provide an
integrated infrastructure to support collaboration. Findings will bring new insights for developing tools to
identify individuals at high risk of PFAS-induced NAFLD to provide an opportunity for early intervention.
Results will contribute to educating the scientific and medical communities and the general public about
the adverse health effects of PFAS, promote evidence-based decision-making in PFAS regulation, and
develop an improved methodology to evaluate the impact of other environmental pollutants on human health.

Public health relevance
PROJECT NARRATIVE Research Project (RP) 1 (RP1) seeks to understand the mechanisms whereby exposure to PFAS chemicals leads to non-alcoholic fatty liver disease (NAFLD), and whether this process is reversible after stopping exposure to PFAS. NAFLD is one of the leading causes of liver disease worldwide and exposure to PFAS chemicals considerably increases the risk of disease progression, however, the mechanisms remain elusive. RP1 proposes a study combining several innovative technologies to provide a more complete understanding of the impact of PFAS on liver metabolism. The conclusion of the proposed project will bring new insights for developing tools to identify individuals at high risk of PFAS-induced NAFLD and provide an opportunity for early intervention, contribute to educating the scientific and medical communities and the general public about the adverse health effects of PFAS, promote evidence-based decision-making in PFAS regulation, and develop an improved methodology to evaluate the impact of other environmental pollutants on human health.